Leveraging Sphingolipid Metabolism for Optimal Response of Breast Cancer Cells to Chemotherapy

While DNA damaging agents such as Doxorubicin (Dox) are highly effective anticancer drugs, their use
is often associated with harmful side effects (e.g. cardiotoxicity and myelosuppression). This leads to their
administration in suboptimal doses, undermining their ability to effectively kill cancer cells. Our P01 group has
also found that sub lethal doses of Dox can actually increase migration of breast cancer (BC) cells, making them
more aggressive. Therefore, the goal of our studies is to maximize the antitumor efficacy of low doses of DNA
damaging agents by sensitizing their cytotoxic potential and minimizing their promigratory effect.
Studies from this P01 and others have linked regulation of individual sphingolipids (SLs) and/or SL
enzymes to actions of Dox in BC cells. Considering that the SL pathway builds on highly interconnected
reactions, the current fragmented and incomplete picture is not conducive to actionable therapeutic decisions.
By applying a global integrative approach that studies metabolism and regulation of the whole pathway,
we are linking distinct SL patterns (both enzyme expression/activity and lipid levels) with cytostatic low (LDox)
or cytotoxic high (HDox) doses of Dox. This approach has allowed us to discover novel nodes of Dox regulation
(e.g., DES1, CERT) and to implicate several modulated SL proteins (nSMase2, ACER2, CERT and SK2) in
biologies elicited by either low or high Dox. Most importantly, targeted modulation of key SL nodes identified by
our approach is able to ‘convert’ the cytostatic LDox response to that of the cytotoxic HDox response. Based on
these compelling data, we propose the hypothesis that identifying and targeting critical nodes of SL
metabolism to mimic the SL response observed with cytotoxic Dox doses will sensitize BC cells to low
Dox doses, while also overcoming dangerous prometastatic functions.
To test this hypothesis, we will pursue 3 aims: Aim 1. Establish integrative approaches to probe global
regulation of the SL network in response to chemotherapy in BC cells (by developing state-of-the-art
methodologies for measurements of SL metabolism and its regulation). Aim 2. Based on predictions built from
the changes in the SL network gathered in Aim 1, target specific SL nodes to sensitize BC cells to low dose
chemotherapy while curbing prometastatic functions. Aim 3. Determine and advance the preclinical efficacy of
inhibition of select critical SL nodes to LDox in vivo, focusing initially on SK2.
Successful completion of these studies will establish, for the first time, a holistic approach to studying SL
metabolism and will identify the most effective biochemical intervention to maximize the antitumor efficacy of
Dox in BC cells. This will serve as a solid platform for the future study of biological SL responses while continuing
to advance cutting-edge-methodologies and approaches for the entire SL field.

Public health relevance
Our studies are leveraging modulation of the sphingolipid pathway in response to DNA damaging agents such as Doxorubicin to maximize their antitumor efficacy while reducing their harmful side effects (e.g. cardiotoxicity and myelosuppression). In doing so, we are also developing state-of-the-art methodologies that will be a tremendous resource for the projects in this P01 and the scientific community.